Community Engagement Core

COMMUNITY ENGAGEMENT CORE
SUMMARY/ABSTRACT
The Community Engagement Core (CEC) will build bidirectional partnerships with target communities to enhance understanding of the health risks posed by emerging water contaminants in the environment (specifically 1,4-dioxane (1,4-DX)), and to provide interventional strategies that will improve public health and inform health policy. In the first phase of the project, the CEC will focus on communities in Nassau and Suffolk counties of Long Island, New York. These communities include residents whose public drinking water wells are impacted by nearby EPA Superfund sites. The CEC will work with the Research Translation Coordinator (in the Administrative Core) to develop replicable tools and resources to provide data and generate knowledge among stakeholders who are invested in addressing water-related issues in the State of New York, especially in areas near Superfund sites. To accomplish this, we will identify effective methods to communicate risk information to each stakeholder group. The specter of emerging contaminants in drinking water is fraught with uncertainty about risk and appropriate courses of action. The CEC will address these challenges through facilitation of stakeholder engagement and information exchange. We will create opportunities for impacted residents and stakeholders from federal, state and local governmental agencies to learn from each other and share information. We will encourage and facilitate multi-directional interactions among communities and experts to complement and support the Yale Superfund Research and Training Program’s (YSRTP’s) overarching objective of fostering research that improves the exposure assessment, health evaluations, and mitigation of emerging contaminants in drinking water in EPA Regions 1 (New England) and 2 (New York, New Jersey, Puerto Rico, US Virgin Islands and eight Tribal Nations) and North Carolina. In addition, we will collaborate with the Research Experience and Training Coordination Core (RETCC) to educate and train the next generation of scientists to conduct community engagement activities. The initiatives implemented in this proposal will be transferable to other communities facing similar challenges including the State of New Hampshire, which will be the second targeted area for CEC activities. We will also be sharing our findings and experience with the North Carolina State University Superfund Center, which is collaborating with the YSRTP’s research projects. The overarching goal of the CEC is to engage and educate residents in impacted communities so they may understand and inform public health policy, and participate in the improvement of public health. Results of this collaborative effort will have a significant impact on the health of human populations in New York and New Hampshire, aid the resolution of similar challenges at Superfund sites throughout the U.S.A., and enhance global efforts to monitor, remediate and determine the impact of water contaminants.

Public health relevance
PROJECT NARRATIVE The uncertainty about risk and appropriate courses of action surrounding emerging contaminants in drinking water, such as 1,4-dioxane (1,4-DX), creates an atmosphere of confusion, blame, anxiety and mistrust in communities impacted by these issues. The focus of the Community Engagement Core (CEC) in the Yale Superfund Research and Training Program (YSRTP) is to address these challenges through facilitation of engagement and information exchange among diverse constituencies in two states currently impacted by 1,4- DX issues (i.e., New York and New Hampshire). The CEC will create opportunities for stakeholders – including residents, government agencies, community and educational organizations – to learn from each other, and by utilizing multilateral partnerships among the projects in the YSRTP, will strengthen relationships across stakeholder groups, foster educational opportunities, and promote active and sustained community engagement.